Flow Cytometry Research Core

The University of Kansas Flow Cytometry Core E is a Chemical Biology of Infectious Disease (CBID) COBRE Core
Laboratory. The Core provides access to flow cytometry and cell sorting instrumentation and expertise to researchers.
Services and training are provided for flow cytometry: cell sorting and multi-parametric analysis of individual cells in
solution, calculated from their fluorescent or light scattering characteristics. The FCC provides assistance in sample
processing, data analysis, instrument training, software support, method and grant assistance, manuscript support, and
consulting. The FCC is a 980 N2 BSL-2 facility equipped with a five-laser BD FACSymphony™ S6 Cell Sorter, a four-laser BD
FACSAria™ Fusion cell sorter, a five-laser Cytek™ Aurora Spectral Flow Cytometer, and other supplemental assay
instrumentation. The Cytek™ Aurora full-spectrum flow cytometry provides users with both tube-based and 96-well
plate based spectral cytometry, with five lasers to allow analysis of 30+ colors. The BD FACS instruments allow
measurement and sorting of up to six resolved populations of cells simultaneously, based on up to 50 parameters of
detection using 18 simultaneous fluorochromes. The facility is equipped to handle BSL-2 samples and perform aseptic
and single cell sorting into tubes or 96-well plates. Both FACS cell sorters are enclosed in biosafety cabinets equipped
with emergency aerosol management systems (AMS). The core provides instrument training for users who desire to
become self-operators of the facility instruments. Core personnel are available for training, assistance with reagent
selection or panel development, and project execution. The Flow Cytometry Core is currently staffed by Peter McDonald
(Core Director, 100% effort, CBID), and Robin Orozco (Faculty Leader, 10% effort, CBID). These investigators run the
sorters, maintain the analyzers and other equipment, and provide expert advice on design and execution of experiments.
The core has multiple offline analysis workstations equipped with flow cytometry analysis packages, including a FlowJo™
site license for data analysis software, providing the components and advanced software for post-acquisition data
analysis and graphics generation. The core stores and protects user data on a research file storage network, protected by
a RAID system. Stored data is accessible within the KU network or remotely via the university's virtual private network.
The core also features proximity key card access to the core for secure 24-hour access. The core is currently utilized by
eight academic departments, with over 50 investigators with 38% who are CBID affiliated. The FC core will equip CBID
researchers with tools directly applicable to infectious disease research, such as identifying and characterizing infectious
agents such as bacteria and parasites, quantification and sorting of cells infected with microbial pathogens, and assessing
chemical probe efficacy against infectious agents. The FC core resources enable monitoring immune responses and
activation status associated with infection, and measuring changes in cellular phenotypes (size, granularity, complexity,
density, expression) in response to compound treatment. The FC core seeks to assist CBID collaborators in achieving their
research goals.